BRONCHIAL CIRCULATION IN ACUTE AIRWAY OBSTRUCTION

To explore the role of bronchial circulation in acute airway obstruction by 1)manipulating bronchial blood flow and vascular engorgement, and 2) by comparing intra-airway temperatures before and after antigen exposure.